Personalized Prediction of Cardiovascular Outcomes through Machine Learning Analysis of Cardiac MRI and Genomics

Scientific Abstract
Clonal Hematopoiesis of Indeterminate Potential (CHIP) is a condition of aging that has been associated with
increased risk of heart disease and heart failure. CHIP is evaluated by DNA sequencing of peripheral blood.
However, not all patients with CHIP will develop heart failure or myocardial infarction. Our preliminary data
demonstrate that CHIP patients (cancer and non-cancer patients) have a higher burden of nonischemic scarring
in their hearts on cardiac MRI compared to patients without CHIP. In a pilot cohort using a machine learning
technique of convolutional neural networks (CNN), we are able to predict who have CHIP with 86% accuracy
and predicted future cardiomyopathy with an accuracy of 73%, thus opening the door to possible image guided
risk stratification for identifying patients with CHIP as well as predict future cardiac outcomes. We also find
through our novel deep learning algorithm that we can identify extended somatic variants that are CHIP-like that
can impact heart failure outcomes and through integration of patient data, genomic and imaging signatures, we
are able to develop partition risk scores that can weigh the variables such as CHIP and their contribution to heart
failure and the pathways involved. We hypothesize that using cardiac MRI, novel machine learning
techniques on large imaging datasets can identify CHIP vs non-CHIP patients as well as predict who will
develop adverse cardiovascular outcomes and that CNNs can be used on both imaging and genomic
signatures in large cohorts like the TOPMED, UKB and All of Us to predict cardiovascular outcomes
while pathway analyses will reveal mechanisms and novel targets for CHIP-mediated cardiomyopathy
Specific Aim #1 will use a novel CNN with multi-view cross-attention to identify MRI features that can accurately
predict CHIP as well as future adverse outcomes such as heart failure and myocardial infarction that will be
validated in large datasets like TOPMed, UKB and All of Us with a collective ~13000 cardiac MRIs. Specific Aim
#2 will use artificial intelligence approaches and a novel analysis pipeline that combines patient data, cardiac
MRI signatures and genomic signatures of CHIP and extended somatic variants that are predictive of
cardiovascular outcomes to help reveal mechanisms behind CHIP’s contribution to cardiomyopathy.

Public health relevance
Project Narrative Clonal Hematopoiesis of Indeterminate Potential (CHIP) is a condition of aging and is associated with increased risk of heart disease, heart failure and worse outcomes in cancer patients. CHIP involves somatic mutations in peripheral blood stem cells and currently can only be evaluated by DNA sequencing of blood. The proposed research will use cutting edge machine learning methods to elucidate unique imaging features in cardiac MRI to identify subjects with CHIP, predict who with CHIP will develop cardiomyopathy as well as integrate MRI, genomics and transcriptomics to identify pathways contributing to cardiomyopathy and potential personalized therapeutic targets.